Clinical Translation and Validation Core

The goal of the Clinical Translation and Validation Core is to use the science and practice of geriatrics and
gerontology to assess the feasibility and clinical utility of artificial intelligence (AI) methods for clinical decision
support and of new technology for monitoring aging adults in their home. Recognizing that geriatric syndromes
and functional and cognitive impairment are the most important predictors of health outcomes and quality of life
in older adults, and that current clinical approaches to identifying and preventing these conditions are reactive,
this core's efforts are rooted in the belief that AI and home monitoring hold tremendous promise for disrupting
the clinical paradigm and revolutionizing the detection, monitoring, and care of older adults and those with
AD/ADRD. The core leadership will use their collective expertise in AD/ADRD, geriatrics, gerontology, and AI to
work closely with the other PennAITech Collaboratory Cores to support training, stakeholder engagement, and
pilot projects that promote the feasibility and utility of AI methods for decision support and new technology in the
home. Together, this team will accomplish the following aims: (1) establish an expert panel to assess the
feasibility and clinical value of new artificial intelligence models for predictive analytics and clinical decision
support and of new technologies designed to monitor aging adults and those with AD/ADRD; (2) collaborate with
the Technology Identification and Training Core and the Networking and Mentoring Core to build and make
available a searchable database of new artificial intelligence software and home monitoring technology for the
purpose of making connections with those interested in collaborating, evaluating, or adopting such tools;
(3) establish a national resource for the evaluation and deployment of artificial intelligence models for predictive
analytics and clinical decision support; and (4) partner with the Stakeholder Engagement Core to establish a
network of sites and settings which can serve as a testbed for new technologies designed to monitor aging adults
and those with AD/ADRD with an emphasis on underserved and rural populations.

Public health relevance
Successful aging in the home can greatly improve quality of life, improve health outcomes, and reduce burden on the healthcare system. The goal of this project is to establish a national collaboratory for the development, evaluation, and implementation of artificial intelligence software and new technologies to facilitate health aging in the home. The goal of the Clinical Translation and Validation Core is to use the science and practice of geriatrics and gerontology to assess the feasibility and clinical utility of artificial intelligence (AI) methods for clinical decision support and of new technology for monitoring aging adults in their homes.